Mitochondrial depolarization, mitophagy, and mitochondrial DAMPs in ALD

Alcohol-associated liver disease (ALD) is the leading cause of liver-related mortality. How ethanol (EtOH)
damages the liver remains poorly understood, and therapies are lacking or unproven. A better understanding of
the mechanisms by which the liver handles, processes, and responds to EtOH is needed to develop strategies
to avoid and treat the dangerous hepatic ramifications of alcohol, particularly fibrosis and cirrhosis. EtOH
consumption produces a swift increase in alcohol metabolism (SIAM) that is associated with a commensurate
increase of mitochondrial respiration. Our work reveals reversible hepatic mitochondrial depolarization
(mtDepo), increased mitophagic burden, and release of mitochondrial DNA (mtDNA) in mice after EtOH
treatment, that precedes hepatic steatohepatitis and fibrosis. Here, we build on these findings to characterize
the signals, pathways, and mechanisms of 1) onset and recovery from EtOH-induced mtDepo, 2) mtDepo-
induced mitophagy, and 3) stellate cell activation and fibrosis downstream of mtDepo. Overall, we hypothesize
that mtDepo is an adaptive response stimulating more rapid mitochondrial NADH oxidation to supply
NAD+ required for EtOH metabolism, but chronically, mtDepo becomes maladaptive, causing disordered
mitophagy and release of mitochondrial damage-associated molecular patterns (mtDAMPs) like mtDNA,
leading ultimately to hepatic end stage liver disease. In Specific Aim 1, we will characterize the mechanisms
of onset and recovery of EtOH-induced mtDepo, specifically the role of opening and closing of different proton
leak pathways in inducing mtDepo and of mitochondrial biogenesis to restore functional mitochondria after EtOH
is metabolically eliminated. In Specific Aim 2, we will characterize the manner of mitophagy after EtOH
treatment. Specifically, we will determine if mitophagy initiated by EtOH-induced mtDepo involves the classical
PINK1/Parkin ubiquitination pathway, is triggered by mitochondrial swelling leading to inner membrane herniation
through a ruptured outer membrane with release of mtDNA as observed in preliminary work, or both. In Specific
Aim 3, we will determine pathways by which mtDAMPs (like mtDNA) (possibly in synergism with acetaldehyde
generated from hepatic EtOH metabolism) elicit a profibrogenic response in stellate cells with particular
attention of the role of mtDNA-sensing toll-like receptor-9 (TLR9) whose deficiency decreases alcohol-induced
liver injury. Together, these aims will increase our understanding of mechanisms underlying both the onset
and recovery from mtDepo and how mtDepo-induced dysregulated mitophagy leads to mtDAMP release
causing stellate cell activation and ultimately hepatic fibrosis. The findings of this project will allow
development of new mechanism-based therapeutics to treat and prevent alcoholic liver disease.

Public health relevance
Project Narrative Alcohol-associated liver disease (ALD) with its associated fibrosis/cirrhosis is the major cause of liver- related mortality. Here, we investigate how ethanol ingestion produces hepatic mitochondrial depolarization (mtDepo) leading to mitochondrial autophagy (mitophagy), release of mitochondrial damage-associated molecular patterns (mtDAMPs) like mitochondrial DNA (mtDNA), and profibrotic responses by collagen fiber- producing hepatic stellate cells. Success of this project will allow development of new mechanism-based therapeutics to treat and prevent alcoholic liver disease.